Administrative Supplement: Mechanisms of inositol trisphosphate receptor-mediated calcium signaling

Project Summary/Abstract (parent award)
The overall objective of this research program is to understand the molecular mechanisms of intracellular calcium
signals that regulate multiple diverse cellular functions, both healthy and pathological. Many of these signals are
due to opening of inositol 1,4,5-trisphosphate receptors (IP3Rs), the most widely expressed ligand-gated Ca2+
channels. IP3Rs reside primarily in the membranes of endoplasmic reticulum (ER) from which they release Ca2+
when they bind both IP3 and Ca2+.The proposed studies focus on uncovering the structural and mechanistic
basis for ligand binding, ion permeation and gating in the family of IP3R channels. IP3Rs work as Ca2+ signaling
hubs through which diverse extracellular stimuli and intracellular inputs are processed and then integrated to
result in delivery of Ca2+ from the ER lumen to generate cytosolic Ca2+ signals with precise temporal and spatial
properties. However, an in-depth understanding of the comprehensive allosteric mechanism governing control
of intracellular Ca2+ signals via IP3R channels is still lacking. Our structural and functional studies accomplished
over the last years, establish the molecular architecture of neuronal IP3R subtype 1 (IP3R1) channel providing
critical insights into channel gating and ligand-binding. Recent advances in our work coupled to our knowledge
and expertise over two decades of research on calcium channels, guide our current research strategy. In this
proposal, we seek to address the fundamental questions of how ligands and modulatory proteins affect the
conformational landscape of IP3R, and how conformational changes in channel structure control and shape its
function. We are pursuing a multidisciplinary approach that includes biochemical, biophysical, mutagenesis,
electrophysiological, cryo-EM and cryo-ET studies to dissect structure-function of IP3Rs. We will use a deep
learning neural network-based method to extract conformational motions of the IP3R domains directly from cryo-
EM images. Continuing with IP3R1, we will elucidate the molecular and structural mechanism for channel gating
and regulation at atomic level detail and define its subcellular organization and dynamics. Another effort will be
directed at defining the structural basis for isoform-specific properties of IP3Rs. To this end, we will determine
high-resolution structures of other IP3R subtypes in multiple functional states. Our structural findings will be
validated by extensive functional analysis. We aim to elucidate the mechanisms of how IP3Rs sense multiple
cellular signals and decode them into cytosolic Ca2+ signals to ensure appropriate regulation of downstream
signaling pathways. The proposed studies will provide a structural framework and the mechanistic knowledge
required for the development of new ways to control IP3R function.

Public health relevance
Project Narrative (parent award) Inositol 1,4,5-trisphosphate receptors (IP3Rs) are calcium channels that are ubiquitously expressed in all eukaryotic cells and play important roles in regulation of a broad range of physiological processes in humans. Dysfunctions in IP3Rs are associated to numerous human diseases, including neurodegenerative diseases such as Alzheimer’s, Parkinson’s and Huntington’s diseases, stroke, and cancer, and therefore these channels are important drug targets. The proposed studies aim to understand the detailed structure and fundamental mechanisms governing IP3R channel function and to elucidate how they are perturbed in disease states that will aid in search for novel therapies to treat disorders related with abnormal cell calcium homeostasis.